Elevated systolic blood pressure, body mass index, and amyloid as drivers of tau and cognitive decline in preclinical Alzheimers disease: critical windows in mid- to late-life

PROJECT SUMMARY/ABSTRACT
This K23 proposal will investigate the timing of the relationship between vascular risk and amyloid (Aβ) on
tau accumulation during the preclinical stages of Alzheimer’s disease (AD), to determine the critical window
for intervention. Our prior studies demonstrated a synergy between specific vascular risks, especially high
systolic blood pressure (SBP) and body mass index (BMI), with Aβ in accelerating tau PET burden and
cognitive decline in preclinical AD. The prevalence and modifiability of hypertension and obesity add to their
excellent potential as combination therapeutic targets with Aβ for prevention efforts in AD. However, the
optimal age group to target for intervention remains unknown. Epidemiology studies suggest that midlife
vascular risks are most strongly associated with increased risk of AD, while effects are mixed or reversed in
late-life. The goal of this project is to address the following key knowledge gaps: 1) how early and over what
age period do elevated SBP and BMI, synergistically with Aβ accumulation, drive greater tau pathology, 2)
whether plasma phosphorylated tau (p-tau) measures may be more sensitive than tau PET in detecting an
early interaction in midlife when the AD pathological burden is low, and 3) how longitudinal changes of these
tau measures relate to the synergistic effects of vascular risk and Aβ on prospective cognitive decline. We
will accomplish these goals using an innovative approach: i) harmonizing the breadth of cross-sectional data
from the Harvard Aging Brain Study (HABS) and Framingham Heart Study across 5+ decades from mid- to
late-life to determine the timing of the vascular-Aβ effects on tau PET (Aim 1) and plasma p-tau (Aim 2), and
ii) leveraging the depth of longitudinal characterization in HABS to elucidate the effects on longitudinal tau
pathology, and determine how changes in tau PET and p-tau relate to cognitive decline (Aim 3). Our findings
will inform the design of combination clinical trials targeting vascular risk and Aβ in preclinical AD, by
identifying the population at risk and by establishing whether plasma p-tau can detect this early synergy,
which can greatly expand accessibility and diversity of research studies. Our preliminary results suggest
that the synergistic effects on tau pathology are greatest during midlife, which has the potential to shift
research and clinical practice paradigms to focus prevention efforts even earlier. This career development
award will be powered by a cohesive mentorship and advisory team of leading experts with complementary
expertise in AD and vascular contribution to cognitive impairment and dementia (VCID). The rigorous training
plan will enable the candidate – a practicing cognitive neurologist with a strong commitment to AD research,
to acquire new expertise in PET methodologies, plasma biomarkers, epidemiology and mechanisms of
VCID, and advanced statistical methods including clinical trials design. The scientific knowledge and
research skills gained from this K23 award will advance the candidate towards an independent clinician-
scientist career to identify, understand, and ultimately intervene on vascular contributions to preclinical AD.

Public health relevance
PROJECT NARRATIVE Vascular risk factors (particularly hypertension and obesity) are important contributors to Alzheimer’s disease, working with amyloid pathology in individuals without symptoms to accelerate the buildup of abnormal tau proteins and drive cognitive decline. This study will provide important missing knowledge about how early and over what age range this interaction takes place and therefore can be intervened upon, and whether imaging or blood measures of tau pathology can detect this early and silent partnership between vascular risk and Alzheimer’s disease in midlife. Outcomes from this project will inform the design of prevention trials targeting both amyloid and hypertension or obesity in asymptomatic Alzheimer’s disease, by identifying individuals who are at risk and are most likely to benefit from early intervention, and by determining whether we can use blood measures of tau pathology to improve accessibility and diversity of these clinical trials.